Center for Cystic Fibrosis Translational Research in the Post-CFTR modulator Era

This P30 Cystic Fibrosis (CF) Research and Translational Core Center (CFRTC) is located at the University of
Washington School of Medicine (UWSOM) and its affiliated institution, Seattle Children’s Research Institute
(SCRI). This proposal updates our already robust P30 center program, with a large basic and clinical research
base at these institutions extremely robust CF related infrastructure funding, comprising 19 departments and/or
divisions across 5 Schools. The UWSOM has a long history of excellence in CF-related translational research
and microbiology, with particular emphasis on the gastrointestinal microbiome, CF related diabetes (CFRD),
and kidney disease in the past 5 years. The research for this P30 will focus on four Specific Aims: 1)
Enhance the research cores and other infrastructure for CF research in NIDDK interest areas to promote
creative, interdisciplinary and clinically-impactful CF research. 2) Provide expertise to researchers
nationally to design innovative clinical studies that determine best practices and develop new therapeutic
approaches to correct dysfunctional CFTR and its secondary consequences. 3) Direct a successful pilot and
feasibility grant program that attracts young and “new to CF” investigators, emphasizing support for
investigators studying CF-related diabetes, GI disease, renal physiology, and other extra-pulmonary disease
manifestations. 4) Train and mentor the next generation of laboratory, clinical, and biostatistical science
leaders in CF locally and nationally. The center will be led by Multi-PDs Christopher H. Goss, MD MSc,
Professor of Medicine and Pediatrics, and Lucas Hoffman, MD PhD, Professor of Pediatrics and Adjunct
Professor of Microbiology, CF investigators both internationally recognized in their respective areas of clinical
research and CF microbiology and gut microbiome. They will be supported by other key leadership: Kathleen
Ramos MD, MSc, Associate Professor of Medicine; Charles Frevert, DVM, ScD, Professor of Department of
Comparative Medicine; Pradeep Singh, MD, Professor of Medicine and Microbiology; Pavan Bhatraju, MD,
MSc, Associate Professor of Medicine; Stephen Salipante MD, PhD, Professor of Laboratory Medicine; Sonya
Heltshe, PhD, Professor of Pediatrics; and Sina Gharib, MD, Professor of Medicine. The center will consist of
an Administrative Core (Goss and Hoffman, Directors) and three biomedical cores: The Clinical and Specimen
(Goss and Ramos, Directors with Frevert and Hoffman), Genomics (Salipante, Director) and Biostatistical and
Informatics Cores (Heltshe and Gharib, Directors). The CFRTC will operate a Pilot and Feasibility (P&F)
program led by Drs. Singh and Bhatraju. Three newly approved P&F projects are included in the current
proposal chosen through a competitive process and approved by the Internal Advisory Board.

Public health relevance
The University of Washington CFRTC focuses its research on developing new and improved treatments for patients with Cystic Fibrosis and understanding the impact of these new therapies on patient health. The Center has a long history of strong partnerships between laboratory and clinically based scientists working together to take observations from the laboratory and transforming these findings into better therapies to treat the nutritional, digestive, metabolic, kidney and systemic aspects of CF. The CFRTC has 3 biomedical cores (Genomic and Genomic Analysis Core, Biostatistics and Informatics Core, and Clinical and Specimen Core), a pilot and feasibility program, an Administrative Core and enrichment programs to encourage research collaborations.